UZIMA-DS: UtiliZing health Information for Meaningful impact in East Africa through Data Science

PROJECT SUMMARY – Overall Component
Africa is the youngest continent in the world, with 60% of its population under the age of 25. The span between
early life to young adulthood represents a critical window where biological, environment and psychosocial events
can significantly impact long- term uzima, which means health/well-being in Swahili. Coupled with the recent
technological advances and the enormous volumes of data collected in Africa, there is an unprecedented
opportunity to leverage data science to identify and improve the health trajectories of young Africans. However,
significant analytical and computational barriers persist that impede our ability to use this information to change
care at the community and individual level. Our proposed Research Hub, UZIMA-DS, aims to change this
narrative by UtiliZing health Information for Meaningful impact in East Africa through Data Science. We will create
a scalable and sustainable platform to apply novel approaches to data assimilation and advanced artificial
intelligence (AI)/machine learning (ML)-based methods to serve as early warning systems to address critical
health issues impacting young Africans in two domains: maternal, newborn and child health and mental
health. Our Hub addresses three critical needs across the translational spectrum of data science: 1)
Harmonization of multimodal data sources for meaningful use and analyses; 2) Leveraging temporal patterns of
data to identify trajectories through prediction modeling using AI/ML-based methods; and 3) Engaging with key
stakeholders to identify pathways for dissemination and sustainability of these models into target communities.
For our Maternal and Child Health Study (Project 1), we will leverage the large and diverse existing data sets in
Kenya, including two demographic surveillance systems, cohort studies and hospital data, to develop and
validate AI/ML-based prediction models to identify women of childbearing age at high risk for poor pregnancy
outcomes (e.g., pregnancy-induced hypertension, low birthweight) and non-communicable diseases later in life
and children at risk of future poor life outcomes (e.g., developmental delays). For our Mental Health Study
(Project 2), leverage existing surveillance data as well as novel mobile technologies (e.g., mobile apps,
wearables) for the development of existing and new AI/ML-based prediction models to identify adolescents and
young healthcare workers at risk of depression and suicide ideation in Kenya. Our Hub and Projects will be
supported by an Admin Core, Data Management and Analysis Core, and a Dissemination and Sustainability
Core, which will facilitate engagement with multisectoral stakeholders to identify sustainable model dissemination
pathways into target communities. Ultimately, our work will empower African researchers to carry forward the
UZIMA-DS Hub to address on-going and evolving health needs of Africans by building sustainable infrastructure,
expertise, and partnerships for long-lasting impact. The UZIMA-DS Hub can serve as a model that can be scaled
to other countries and health domains with the greater DS-I consortium to transform care delivery in Africa,
ensuring that current and future generations of Africans can achieve uzima.

Public health relevance
PROJECT NARRATIVE – Overall Component Our proposed Research Hub, UZIMA-DS (UtiliZe health Information for Meaningful impact in East Africa through Data Science) will create a scalable and sustainable platform to apply novel approaches to data assimilation and advanced artificial intelligence/machine learning-based methods to serve as early warning systems to 1) improve health outcomes for at-risk mothers and children and 2) improve mental health outcomes for at-risk adolescents and young adults in Kenya. We will bring together method experts in statistics, computer science, and informatics, health domain experts and practitioners, and partnerships with key stakeholders to not only improve the quality, efficiency, and relevance of multidisciplinary data science in health research, but also its transparency, reproducibility, and dissemination for sustainable impact in Africa. Thus, helping ensure current and future generations of Africans can achieve uzima (health/well-being in Swahili).